Novel Stealth Lipid for use in HIV MPER Vaccine

PROJECT SUMMARY
A critical roadblock to HIV vaccine development is the inability to induce B cell lineages of broadly neutralizing
antibodies (bnAbs) in humans. The HVTN 133 clinical trial (NCT03934541) utilized a peptide-liposome
immunogen targeting B cell lineages of the HIV-1 envelope membrane-proximal external region (MPER). The
MPER peptide-liposome administered during this clinical trial successfully induced polyclonal HIV-1 B cell
lineages of mature bnAbs, the most potent of which neutralized 15% of global tier 2 HIV-1 strains and 35% of
clade B strains. While this trial demonstrated proof of concept and outlined a potential path for successful HIV-1
vaccine development, the trial was halted due to a polyethylene glycol (PEG)-associated anaphylaxis reaction
that has now been attributed to the use of PEG-lipid. To address this issue, Gateway Bio proposes to replace
the PEG-lipid used in previous MPER peptide-liposome formulations with a lipid tethered to poly(oligoethylene
glycol) methyl ether methacrylate (POEGMA), a next-generation polymer that resembles PEG but is tailored to
address the existing limitations of PEG. POEGMA comprises a brush polymer structure with tri(ethylene glycol)
sidechains along a poly(methyl methacrylate) backbone. The high density of tri(ethylene glycol) sidechains fully
maintains the stealth properties of PEG, but this unique architecture limits the number of consecutive ethylene
glycol units to just 3 repeats, which prior studies have shown eliminates PEG antigenicity—the binding of pre-
existing anti-PEG antibodies to POEGMA, and mitigates anti-POEGMA immune reactions—the formation of new
antibodies which recognize POEGMA. The goal of this proposal is to support a restart of the promising MPER
peptide-liposome vaccine platform for HIV by developing a suitable POEGMA-lipid capable of replacing the
problematic PEG-lipid that led to premature termination of the original clinical trial.

Public health relevance
PROJECT NARRATIVE A promising clinical trial of a peptide-liposome based vaccine demonstrated proof of concept for successful HIV- 1 vaccine development. However, this trial was halted due to a life-threatening polyethylene glycol (PEG)- associated allergic reaction. Through this proposal, Gateway Bio proposes a solution to this problem that will enable this clinical trial to be restarted by replacing the PEG in the original peptide-liposome vaccine formulation with an alternative polymer that has the same desirable properties as PEG but does not trigger an allergic response to the vaccine.